Administrative Core

SUMMARY – ADMINISTRATIVE CORE
The Administrative Core (Admin Core) will function as the organizational and scientific hub of the Center to
ensure success of the research projects and cores that make up the foundation of the Center. This will be
accomplished by promoting effective governance, efficient management, good communication, and a strong
culture of collaboration among all investigators that encourages creativity, knowledge sharing, and scientific
rigor. The Admin Core will be responsible for the overall organization of the Center including the scheduling
of teleconferences and meetings, engagement of the External Scientific Advisors and interactions with NIH
program staff. In addition, the Admin Core will coordinate the community engagement activities. Finally, the
Admin Core will lead efforts to communicate Center activities and findings to the public and scientific
community through maintenance of a website, strategic use of social media, scientific publications,
presentations at national and international conferences, resource sharing and data dissemination. The
Administrative Core will pursue the following Specific Aims: Aim 1) Manage and coordinate all administrative
and collaborative activities of the Center. This Aim will involve organization and leadership of the Center,
formation of an Executive Committee, interaction with the Internal and External Advisory Boards, writing a
Center Charter, promoting scientific rigor and reproducibility, conflict resolution as well as student and
postdoctoral training. Aim 2) Facilitate communication across participating institutions and community
partners. This Aim will involve organization of project and core team meetings, of a seminar series and an
annual meeting, community engagement, and reporting to NIH. Aim 3) Enable public awareness of Center
activities and ensure timely resource sharing. This Aim will involve creating a Center website, social media
outlets, as well as resource sharing and dissemination of results.